National Resource for Advanced NMR Technology

A major part of the scien�ﬁc program of the parent project (1RM1GM148766) is based on the world’s
highest ﬁeld high resolu�on NMR magnet, the 36 T series connected hybrid (SCH). This instrument is
opening new fron�ers in the studies of a wide array of biological systems, chemical compounds, and
advanced materials. A groundbreaking ﬁeld regula�on system was developed and implemented for the
SCH which suppresses ﬁeld ﬂuctua�ons down to 0.3 ppm and has enabled a variety of NMR experiments
– as proven by the extensive publica�on record in the last ﬁve years. We are ready to take the next step
and enable the SCH to make unmatched measurements of spin-1/2 nuclides in biological systems. This
will require speeding up the control loop of the ﬁeld regula�on system from a rate of 40 Hz to a rate of
about 1 kHz. Extensive preliminary tes�ng on our current system has demonstrated the improvement
possible with a faster control loop. To accomplish this increase in speed, we propose to replace our ca.
2013 Na�onal Instruments electronics with the much more powerful 2024 version. The new hardware
has the increased FPGA fabric and backplane data transfer capability to make the faster control loop
possible. It also runs a currently supported development environment and will be compliant with ever
increasing LAN and internet security requirements. The ﬁeld regula�on technology developed with the
new system may ﬁnd applica�on in regula�ng nonpersistent NMR magnets based on high temperature
superconductors.

Public health relevance
NMR spectroscopy uses strong magnets and radio frequency technology in the study of metabolomics and the structural biology of proteins, membrane proteins and complexes they form, providing powerful means for understanding how structure, dynamics, and chemistry drive functional mechanisms. We propose to purchase new equipment essential to improving the world’s strongest magnet used for NMR spectroscopy. The improved facility will be available for biologists, biomedical engineers and all scientists with projects that require its unique capabilities.